High-Throughput DNA Sequencing System

Abstract: Project Summary
This grant proposal requests funding for a NovaSeq X Plus system manufactured by Illumina,
San Diego, CA. This instrument will be incorporated into a successful Genomics facility, the
Molecular Biology Core Facilities (MBCF) at the Dana-Farber Cancer Institute (DFCI). This core
facility has provided molecular biology services, both genomic and proteomic, by chargeback
since 1984. The NovaSeq X Plus will be used as a high impact expansion, complementary to
existing Next-Generation sequencing services currently provided by the MBCF on two Illumina
NextSeq 550s, 4 MiSeqs, a MiniSeq and a NovaSeq 6000. This expansion will allow cost
effective and rapid turnaround time for whole genome sequencing, whole genome methylation
profiling, single-cell genomics, and spatial transcriptomics applications. The increased capacity
and substantially less expensive cost per basepair will increase the economic feasibility of much
larger projects and improve access to cutting edge technology for smaller projects.

Public health relevance
Project Narrative Rapid and cost-effective whole genome sequencing, methylation profiling, single-cell and spatial genomics is now possible with the Illumina NovaSeq X Plus. This technology will enable deeper insights into genetic and epigenetic regulation as well as disease progression.